IGF::OT::IGF Support for Biomedical and Clinical Information Services for the National Library of Medicine and Other NIH Institutes and Centers

This agreement will help maintain, expand and ensure the continuity of AIDSinfo, a comprehensive government resource for the dissemination of information on HIV/AIDS medical practice guidelines, HIV/AIDS treatment and prevention clinical trials, and other research-related information.